Harnessing endothelial cell transdifferentiation for cardiovascular therapy

Cardiovascular disease is the leading cause of death, so recent efforts have focused on using
emerging genetic technologies to remediate cardiac and vascular pathologies. These efforts are largely
based on a growing number of studies, including our preliminary data, that have observed transgene
delivery to cardiac myocytes via intravenous injection of a viral vector. However, to date, there is no
empirically backed rationale for any mechanism underlying this important finding. My lab has focused
on the prospect of endothelial cell transdifferentiation for many years and accrued evidence that this
process exists in adult mice and may be responsible for the homeostasis of diverse cell types. Our
preliminary data coupled with our proposed approach will determine whether cardiac myocyte labeling
is the result of a transdifferentiation event (endothelial cell or otherwise) or the product of extracellular
vesicle transfer. This work will also confirm whether the source of this labeling is endothelial cells. We
are also interested in determining the nature of intravenous transgene delivery to other cell types, which
could yield information about the localization of endothelial cell transdifferentiation to discrete niches.
The existence of such niches could have important implications for enhancing the vascular pathology
of those regions. This work will be undertaken using separate state-of-the-art cell lineage tracing
strategies that encompass virus, protein, and cell-based methods. The answers provided by this study
will help guide efforts for cardiac genetic therapy, advance our understanding of endothelial cell biology,
and provide potentially new insights into cardiovascular disease.

Public health relevance
The proposed work will determine if cardiac myocytes are naturally replenished in adult mice through transdifferentiation of endothelial cells or if endothelial cells make cytoplasmic contributions to cardiac myocytes through extracellular vesicle transfer. This question will be explored using advanced cell lineage tracing methods. Knowledge gained from the proposed study could lead to an improved understanding and the development of novel strategies that harness endothelial cell function for cardiovascular therapies.